Elucidating the role of c-Abl in Wnt-dependent tumors

Title: Elucidating the role of c-Abl in Wnt-dependent tumors.
Project Summary:
Wnt signaling is a ubiquitous cell signaling pathway that has been studied for decades, with critical roles
in organism development and tissue homeostasis. Wnt signaling is a tightly controlled system, which requires
Wnt ligand binding to the receptor complex to lead to a cascade of events, resulting in -catenin translocation to
the nucleus to activate downstream transcription programs. There are numerous negative regulators in this
process – including the rate limiting step of Wnt ligands binding to the receptor, and the destruction complex
which degrades -catenin when the receptor complex is unbound by Wnt ligands. However, when these negative
regulators fail and Wnt signaling is aberrantly activated, various developmental defects and numerous diseases,
including cancer, arise. Therefore, regulators of Wnt signaling have been extensively studied, yet there are no
FDA-approved therapies to target aberrantly active Wnt signaling.
Our preliminary data suggests that Abelson tyrosine kinase 1 (c-Abl) is a novel, positive regulator of
Wnt/-catenin signaling. To identify the how c-Abl regulates Wnt/-catenin signaling, the effects of Abl over-
expression (c-Abl and Abl2), Abl mutants of constitutive activity and domain knockouts using pcDNA based
plasmids, small interfering RNA, and small molecule inhibitors of Abl, will be evaluated in Wnt-responsive cell
lines and intestinal organoids. Next, an epistasis analysis will be performed to ascertain where Abl regulates the
Wnt/-catenin pathway – upstream or downstream of the destruction complex. Subsequently, a combination of
an in silico analysis and molecular genetics engineering will identify Wnt-regulated c-Abl interactors to further
underpin how c-Abl regulates Wnt signaling. Then, after extensively studying the mechanism of c-Abl regulating
Wnt signaling, I will determine if c-Abl is required for Wnt-dependent PDAC models. I will use PDAC cell lines
and patient derived organoids (PDOs) to study its requirement in vitro, which will be followed up by orthotopically
transplanted patient derived organoids and xenografts, derived from matched tumors and patients to the PDOs,
to study Abl’s requirement for Wnt-dependent tumorigenesis in models which most accurately recapitulate
human disease.
Successfully completing the project outlined within this award application will advance scientific
knowledge on cell signaling, and will potentially outline a novel approach to treat a subset of Wnt-dependent
cancer with FDA approved small molecules.

Public health relevance
Project Narrative: There are several cell signaling pathways that dictate animal development, which can also give rise to various diseases, including cancer, when they do not function properly. This proposal explores a previously unidentified regulator in one of these pathways, and how it can pertain to cancer. Further, there are already a number of FDA-approved drugs against this new regulator, which we have preliminarily shown can halt the growth of a subset of pancreatic cancers and will explore further.